Role of Plasminogen Activator Inhibitor-1 in Vascular Smooth Muscle Cell Stiffening and Senescence

Vascular smooth muscle cells (SMCs) are present throughout the arterial tree and play a central role in
cardiovascular physiology by regulating blood pressure and flow. Cardiovascular aging is characterized by
pathologic changes in SMCs that contribute in a major way to high-burden diseases affecting US veterans,
including hypertension, atherosclerosis, myocardial infarction, stroke, and peripheral artery disease. Two
important phenotypic changes that occur in SMCs with aging are 1) stiffening, which produces hypertension
and increases cardiac afterload, and 2) senescence, which is functionally defined as arrest of cell division and
assumption of the senescence-associated secretory phenotype (SASP), a driver of vascular inflammation and
fibrosis. Plasminogen activator inhibitor-1 (PAI-1), a member of the serpin superfamily of protease inhibitors, is
the primary inhibitor of tissue-type plasminogen activator (t-PA) and urokinase (u-PA) and an important
regulator of proteolysis and cell adhesion. PAI-1 expression increases with age and is associated with
vascular fibrosis and generalized cell senescence. However, the specific effects of PAI-1 on SMC stiffening
and senescence, as well as the mechanisms underlying them, are poorly understood. In preliminary studies
involving pharmacologic and genetic modulation of PAI-1 expression in SMCs, we have shown that drug
targeting of PAI-1 decreases SMC stiffness, assessed by atomic force microscopy (AFM), while also
decreasing SMC cytoskeleton formation and enhancing activation of cofilin, which degrades filamentous (F)-
actin. We also have demonstrated that PAI-1 promotes SMC senescence by a pathway involving the LDL
receptor-related protein-1 (LRP1), while also dampening mitochondrial respiratory fitness, which is strongly
linked to cell senescence. We have performed an RNA-sequencing analysis that has identified candidate
signaling pathways mediating PAI-1’s effects on SMC stiffness and senescence. We also have generated
mice with conditional knockout of PAI-1 in SMCs, which will enable us to study the significance of our findings
in vivo. Based on our extensive preliminary data, we hypothesize that PAI-1 1) regulates SMC stiffness by
controlling actin, myosin, and focal adhesion assembly in the cytoskeleton, and 2) promotes SMC senescence
through adverse effects on mitochondrial energy substrate utilization and reactive oxygen species accrual. To
test these hypotheses, we propose the following specific aims: 1) identify the intracellular signaling pathways
by which PAI-1 regulates SMC stress fiber formation and stiffness, 2) determine the role of PAI-1 in regulating
mitochondrial substrate utilization and reactive oxygen species accumulation in SMCs, probing underlying
mechanisms, and 3) study the effects of pharmacologic and SMC-specific inhibition of PAI-1 on arterial
stiffness and senescence in vivo. Several innovative strategies will be employed, including 1) AFM, 2)
confocal fluorescence microscopy, 3) quantitative studies of PAI-1’s effects of F-actin, myosin, and focal
adhesion assembly, 4) measurement of mitochondrial energy substrate utilization and membrane potential,
and 5) novel murine models that enable quantification of the effects of systemic inhibition and SMC-specific
deletion of PAI-1 on vascular stiffening and senescence in vivo. The experiments will be carried out by a
highly experienced, multi-disciplinary team of scientists from the Truman VA Hospital, the University of
Missouri School of Medicine, and the Dalton Cardiovascular Research Center. The significance of the
proposed work is that it will 1) identify mechanisms by which PAI-1 and its pharmacological inhibition regulate
key degenerative changes that occur in SMCs with aging, namely stiffening and senescence, and 2) translate
these findings to the in vivo setting. The proposed experiments will yield important new information about the
roles of PAI-1 and SMCs in vascular aging that are directly relevant to major cardiovascular diseases affecting
the US veteran population. The studies also have great potential for transition to the clinical setting through
the use of pharmacologic PAI-1 inhibitors.

Public health relevance
Healthy arteries stretch with each heart beat to receive blood pumped from the heart, then constrict to propel blood forward to target organs. With normal aging and in response to several diseases, arteries stiffen, which plays a key role in major cardiovascular diseases, including hypertension, heart failure, and stroke. Arteries contain smooth muscle cells (SMCs), which constrict and relax to regulate blood flow. It recently became recognized that SMCs themselves stiffen with aging. In addition, SMCs, like other cells throughout the body, become senescent, which leaves them unable to divide and makes them secrete proteins that promote inflammation. This proposal will examine how plasminogen activator inhibitor-1 (PAI-1), a protein that controls blood clotting and several cell functions, promotes stiffening and senescence of SMCs and arteries. The effects of drug inhibition of PAI-1 will also be examined, which we anticipate will lead to new approaches to prevent vascular stiffening and its serious adverse effects.